Neural Mechanisms of Behavioral Variability and Strategy Selection in Larval Zebrafish

Abstract
Survival in dynamic environments requires the ability to switch between exploiting an established action and
exploring potentially better alternatives. This strategy switch consists of multiple processes: one that recognizes
when the current behavior is no longer successful and abandons it in favor of exploration in action space, and
another that promotes the maintenance of successful behavioral programs. A critical component of action
exploration is behavioral variability. While broad brain regions have been identified as being involved in (1) the
behavioral variability component, for example the cortical region LMAN in juvenile songbirds, and (2) the
exploratory versus exploitatory strategy tradeoff, for example the midbrain dopaminergic system and the locus
coeruleus noradrenergic network in rodents, the generative algorithms and circuit-level implementation of
computations underlying the control of behavioral variability and the switch to exploratory behavior are not
known. Identifying such motifs in mammals and birds is challenging because of their behavioral complexity and
their large brain size. Larval zebrafish are an ideal system for developing mechanistic understanding of
behavioral variability and exploration versus exploitation of motor programs because of the simplicity of their
behavioral repertoire and because they are small, transparent, and genetically tractable. Therefore, I will use
larval zebrafish, to understand the neural mechanisms underlying behavioral variability and the exploration
versus exploitation of motor programs. In Aim 1, I will optimize an existing virtual reality behavioral paradigm for
larval zebrafish based on the optomotor response to trigger exploration of motor strategies. In Aim 2, I will design
an experimental protocol to induce larval zebrafish to switch from an exploratory to an exploitatory strategy.
Detailed analyses of swim bout kinematics in combination with whole-brain functional imaging during both
experimental preparations will enable the characterization of neural circuits responsible for increased behavioral
variability in exploration and the exploratory versus exploitatory tradeoff. Completion of this project will yield a
comprehensive and quantitative model of the neural basis of the complex task of action selection in different
contexts. Because identification of optimal motor strategies requires exploration of any organism’s motor
repertoire, these principles may suggest generalizable motifs across the animal kingdom.

Public health relevance
PROJECT NARRATIVE Selecting appropriate actions according to context is a complex task that all animals must perform in order to survive. In this project, I will use larval zebrafish to characterize how activity in the brain gives rise to trying alternative behaviors when current actions are not working and to investigate the neural mechanisms underlying the strategy switch from exploring different actions to repeating a stereotyped movement. This knowledge is expected to contribute novel insights to the neural basis of action selection.